Graduate and Postdoctoral Training in Environmental Health Science and Toxicology

SUMMARY/ABSTRACT
The Training Program in the Environmental Health Sciences and Toxicology has as its vision to assure that
trainees gain the skills they need to develop as successful independent, transdisciplinary, ethically engaged
environmental health researchers and practitioners in a program informed by and aligned with the NIEHS
mission - to learn how the environment affects people in order to promote healthier lives and to conduct and
translate research that meets individual and community needs. This renewal builds on the 20 years of success
in training environmental health scientists, a commitment to innovation to meet the evolving needs of
environmental health and toxicology, and a robust and broad portfolio of environmental health sciences
research led by 41 training faculty and supported by nearly 140 research projects and grants, a NIEHS P30
Core Center, a NIEHS Children’s Translational Research Center, as well as collaboration with numerous other
centers and programs throughout the University. Predoctoral trainees take rigorous coursework in their first two
years to gain a comprehensive base of knowledge aligned around four Core Training Elements: (1) exposure
science, (2) biological mechanisms of susceptibility and disease, and (3) environmental determinants of
population health, and (4) environmental justice. For both pre- and postdoctoral trainees, mentored research
sits at the center of this training program, allowing trainees to gain an in-depth understanding of a specific topic
through their chosen mentor and project, aligned with the Core Training Elements, and trainees have
developed projects in molecular and neurotoxicology, environmental epidemiology, exposure science,
environmental determinants of infectious and chronic disease, genomics, and metabolomics. This is
supplemented by training in the responsible conduct of research and ethics, rigor and reproducibility of
research, communication and grant-writing skills, teaching, and numerous opportunities for professional
development and management training. We propose to continue the support of six predoctoral and three
postdoctoral trainees. Predoctoral trainees hold bachelor’s and often master’s degrees in basic science, public
health, or engineering disciplines, and postdoctoral trainees must hold a doctoral degree in environmental
health, epidemiology, toxicology, environmental engineering, or related basic or public health science
disciplines. All trainees must demonstrate a commitment to research and a career in the environmental health
sciences and/or toxicology. Our program has had success in recruiting and retaining individuals historically
under-represented in science, and we have numerous programs in place to continue and increase these
opportunities. Trainees completing this program are entering research intensive positions academic,
government, non-profit, and for-profit sectors. We aim to continue the tradition of excellence in providing
trainees a multidisciplinary training experience to successfully pursue complex problems in the environmental
health sciences and toxicology and make an impact on community health.

Public health relevance
NARRATIVE This T32 training program in the Environmental Health Sciences and Toxicology is designed to assure that trainees gain the skills they need to develop as successful independent, transdisciplinary, ethically engaged environmental health researchers and practitioners. It builds upon our unique focus on exposome research and affords trainees the opportunities to gain a holistic and rigorous knowledge-base, perform innovative research, and gain skills to excel in careers addressing significant public health challenges related to environmental exposures.